Interrogation of SidB-dependent septation for echinocandin potentiation in invasive aspergillosis treatment

Invasive pulmonary aspergillosis (IPA), caused mainly by Aspergillus fumigatus, is a severe infection with
mortality rates up to 90%. These infections are characterized by invasive penetration of septate hyphae into host
tissues. As resistance to antifungal drugs becomes more common, these difficult-to-treat infections are at risk of
becoming more so. The echinocandin antifungal class are well-tolerated cell wall biosynthesis inhibitors yet are
limited in use against IPA. This is mostly due to their fungistatic anti-Aspergillus activity and association with a
paradoxical induction of growth at high concentrations leading to frequent treatment failure. Enhancing
echinocandin efficacy carries the promise of significantly improving patient outcomes for IPA. In a screen for
protein kinases that are required for survival in the face of echinocandin stress, our laboratory identified that
septation-deficient Aspergillus mutants are highly susceptible to echinocandins in vitro and, excitingly, struggle
to invade mouse lung tissue during infection. We found each member of the Septation Initiation Network (SIN)
kinase cascade to be required for septation, intrinsic echinocandin resistance, and virulence of A. fumigatus. My
preliminary data have uncovered the terminal SIN kinase, SidB, as critically important for further study. SidB is
a putative Nuclear Dbf2-Related (NDR) kinase that is predicted to require multiple steps for full activation. The
first of these steps typically includes the N-terminal binding of a conserved MOB-family protein to stabilize protein
conformation and enable downstream phosphorylation events. From a genetic study of five candidate SIN
regulatory proteins, I have found that loss of only the putative SidB binding partner, MobA, results in a mutant
that completely phenocopies pathway inactivation via loss of a SIN kinase. A mobA deletion mutant displayed
aseptate hyphae and was avirulent in a mouse model of IPA. Importantly, loss of mobA resulted in fungicidal
echinocandin activity. Therefore, either loss of the SidB kinase or of its major activating partner, MobA, results in
echinocandin hypersensitivity and impaired virulence. Taken together, our findings support the idea that inhibition
of (i) SidB kinase activity, (ii) SidB/MobA binding, or (iii) downstream effectors of SidB/MobA could each prove to
be successful avenues for improving anti-Aspergillus echinocandin activity as well as blocking deadly tissue-
invasive growth. My objective in this proposal is to define the roles of SidB in pathogenic growth by methodically
delineating its activation and important effectors during septation and echinocandin treatment. We will achieve
this objective by identifying phosphorylation events that are necessary for SidB-dependent septation (Aim 1) and
uncovering novel SIN effectors regulating septation and echinocandin resistance (Aim 2). This work will provide
critical understanding of how SidB contributes to septum formation towards Aspergillus pathogenesis. Septation
blockage via SidB inhibition could be a promising way to increase echinocandin activity for IPA patients. This
knowledge can provide key context for developing novel antifungal drugs targeting septation machinery.

Public health relevance
Invasive pulmonary aspergillosis is associated with high mortality and therapy is complicated by antifungal resistance. Our work focuses on understanding the process of fungal septation, based on strong preliminary data showing that blocking this process can decrease disease severity and improve antifungal drug activity.